Sleep and Temperature Disturbance as risk factors for Alzheimer's Disease in Down Syndrome: a Longitudinal Study

Project Summary Abstract
Down syndrome (DS), the most frequent form of intellectual disability of genetic origin, involves a >95%
cumulative risk of Alzheimer’s Disease (AD) by the seventh decade. Further, AD is now the most common cause
of death in this population as life expectancy in DS individuals has increased. Importantly, while AD in DS
individuals has a mean age of onset 20–30 years younger compared to euploid individuals, there is substantial
heterogeneity in this age of onset (between 40 and 70 years old), emphasizing the urgent need to identify and
treat modifiable causes of AD in DS. Our work in the Down Alzheimer Barcelona Neuroimaging Initiative (DABNI)
Cohort has established that clinical and Amyloid/Tau/Neurodegeneration (ATN) related biomarker changes in
DS have a similar temporal profile to that in sporadic and autosomal dominant AD, meaning these biomarkers
may be used to identify modifiable causes of AD in DS individuals prior to AD dementia onset. Existing literature
and our preliminary data suggest that potential causes of AD in euploid individuals, namely age-related sleep
and body temperature (Tb) circadian rhythm disturbance, are more severely perturbed in DS compared to
euploid older adults: specifically, results suggest that greater obstructive sleep apnea (OSA) severity and lower
Tb are particularly important modifiable AD risk factors in DS. This project will test the hypotheses that greater
baseline OSA severity and lower baseline Tb will longitudinally predict ATN AD biomarker increase and cognitive
decline in initially cognitively stable DS adults. We will recruit 60 DS adults with normal cognition aged 40–60
years old and follow them longitudinally at three annual timepoints over 2 years. Baseline assessments will
include screening; cognitive evaluation; at home and in lab polysomnographic assessments overlapping with 36
hours of telemetrically measured Tb data collection, and collection of ATN biomarkers including amyloid
(flutemetamol PET SUVR, plasma Aβ), tau (PI-2620 PET SUVR, plasma T-tau and P-tau181) and
neurodegeneration (hippocampal volume, cortical thickness, plasma neurofilament light) related biomarkers.
Follow-up cognitive evaluations and collection of plasma-based biomarkers will occur annually at all three
timepoints, and neuroimaging-based biomarkers at two timepoints (baseline and 2 years). The goals of this study
are to test 1) Whether greater baseline OSA apnea hypopnea index (AHI3A) is associated with ATN biomarker
severity (Aim 1), 2) Whether lower baseline Tb is associated with greater tau biomarker severity (Aim 2), and 3)
Whether OSA severity and lower Tb longitudinally predict greater estimated rate of change in AD biomarkers
(Aim 3). Predictors of cognitive decline and additional sleep and Tb parameters will be explored. This novel
proposal will advance our understanding of how age-related sleep and thermoregulatory disturbances impact
AD biomarker progression in people with DS—a population at high risk for all three AD, OSA, and temperature
dysregulation—with the aim of identifying modifiable risk factors in both DS and euploid individuals.

Public health relevance
PROJECT NARRATIVE Down syndrome (DS), the most frequent cause of intellectual disability and the most frequent form of Alzheimer´s disease (AD) of genetic origin, involves an ultra-high risk for developing AD (>95% in the seventh decade). While the age of AD onset in people with DS is on average ~20–30 years younger than in sporadic AD, there is considerable heterogeneity, with some individuals developing AD later in life. This project focuses on sleep disturbance and impaired circadian thermoregulation as potentially modifiable risk factors for AD, which may lead to interventions to delay AD onset in people with DS.